Molecular mechanisms of axon guidance and neural connectivity

7. Project Summary/Abstract
This proposal focuses on defining the molecular mechanisms of axon navigation and connectivity. A normal
functioning human nervous system requires the interconnection of billions of neurons. Improper formation or
maintenance of these connections leads to abnormalities that result in mental diseases and disorders. How are
these connections assembled and integrated? Research has revealed that the molecular mechanisms of axon
guidance and connectivity are well-conserved between simple and complex animals. Simple animals like flies
use many of the same guidance signals as mammals. Therefore, as a step towards understanding how
complex nervous systems form and properly function, we have pursued a strategy to determine how the simple
model fly nervous system is assembled – where we can also apply high-resolution molecular, genetic,
biochemical, cellular, and imaging approaches to solve this problem. Indeed, the goal of my research program
is to focus on a group of axons within the simple nervous system of the fly embryo and characterize the
molecules and mechanisms that guide them to their targets. In particular, elegant studies from multiple labs
have now identified numerous extracellular cues and receptors that guide axons, revealing fundamental
mechanisms of how axons form connections. Far less is known, however, of the intracellular signaling
pathways and mechanisms that link these guidance cues and their receptors to the control of axon navigation.
Likewise, these guidance cues work to either attract or repel axons. Yet, how navigating axons choose
between these antagonistic signals when they simultaneously encounter them remains far from clear. To
answer these questions, we have focused on one of the largest protein families involved in connectivity, the
Semaphorins (Semas) and their Plexin cell-surface receptors. Employing these strategies, our work has
uncovered critical new molecules and mechanisms directing guidance/connectivity. Namely, we have
discovered MICAL family enzymes, and have found that MICAL and SelR enzymes employ a specific
reversible biochemical mechanism to control guidance/connectivity. We have also discovered that precise
connectivity occurs via direct links between Semas/Plexins and other guidance molecules including Integrin-
mediated adhesive receptors, specific growth factors, cyclic nucleotides, adaptors, small GTPases, serine-
threonine and tyrosine kinases, and cytoskeletal assemblers and disassemblers. Now, using these strategies,
our preliminary results uncover that these specific molecular pathways that provide connectivity to neurons are
spatiotemporally and directly instructed by specific molecular pathways that provide metabolic sustenance to
neurons. We therefore hypothesize that specific factors that govern neuronal connectivity are directly, locally,
selectively, and instructively controlled by specific factors that govern neuronal metabolism. We propose to test
this biomedically significant and innovative hypothesis by employing rigorous molecular, genetic, biochemical,
cellular, and imaging approaches and the robust Drosophila high-resolution model system.

Public health relevance
8. Project Narrative Our nervous system controls such remarkable abilities as learning, speaking, and walking only because our neurons communicate in highly organized networks. The goal of this proposal is to characterize the molecular and biochemical mechanisms that enable neurons to find and connect with one another during development and maintain these proper connections through-out adulthood. Understanding how these connections are assembled, integrated, and maintained will suggest solutions to diminish the burden of mental illness, reveal fundamental mechanisms underlying thought, emotion, and behavior, identify therapeutic strategies for multiple brain diseases and disorders, and contribute to healthy recovery following neural trauma.